The Exercise and Physical Activity Collaborative Team (ExPACT): a Proposed MoTrPAC Clinical Center

Project Summary
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) is designed to discover
and characterize the range of molecular transducers (the ‘molecular map’) that underlie the
effects of physical activity (PA) in humans. Our Exercise and Physical Activity Collaborative
Team (ExPACT) –an alliance of the University of Alabama at Birmingham Center for Exercise
Medicine (UAB), Translational Research Institute for Metabolism and Diabetes in Orlando,
Florida (TRI-MD), and Ball State University Human Performance Laboratory (BSU) –has
extensive experience performing highly-controlled aerobic (AT) and resistance (RT) exercise
training clinical trials in healthy and diseased populations. The overarching goal of ExPACT
is to contribute substantively to successful MoTrPAC planning, execution, and innovation.
Phase 1 has already been completed and consisted of: Aim 1) Effectively collaborate with
MoTrPAC leaders and NIH leadership to help guide and finalize the structure and standard
operating procedures (SOPs). In the remaining years of the project, the ExPACT will implement
and complete Phase II and Phase III, as follows: Phase II (Recruitment and Testing Years) Aim
1. We will enroll 420 sedentary but healthy men and women 18+ y into a rigorously controlled,
12-wk, randomized trial of AT (n=140), RT (n=140), or no-exercise control (CON, n=50).
ExPACT geography will enrich MoTrPAC racial, ethnic, urban, suburban, and rural diversity.
The design incorporates comprehensive phenotyping to assess fitness and clinical outcomes,
and human tissue phenotyping to link the molecular transducers with key biological responses
to exercise. Aim 2. Pre-and posttraining, we will obtain strategically timed biospecimens before
and after acute exercise. To better understand the biological extremes, we will conduct the
same acute response studies in highly-trained athletes (AT (n=25) or RT (n=25)). Serial
biospecimen collection in CON will allow estimation of biological, seasonal, circadian and
methodological variability. Aim 3. To enhance the overall scientific impact of MoTrPAC, we will
continue to work with the consortium to conduct ancillary studies, which will markedly
augment subject and tissue phenotyping and interpretation of the molecular maps. Phase III
(Close-out) Aim 1. We will complete all ExPACT data entry, quality control, and central deposit
procedures in collaboration with the MoTrPAC Coordinating Center, and we will actively
contribute to the completion of biospecimen analyses, manuscript writing, and dissemination of
results. We would be honored to collaborate with MoTrPAC to contribute future knowledge on
the molecular mechanisms through which physical activity can improve or preserve health.

Public health relevance
Project Narrative While there are many important health benefits of physical activity and rigorous exercise training, the underlying mechanisms are poorly understood. A more comprehensive understanding of the molecular mechanisms would substantially impact public health by provided new information that may be leveraged to treat disease. To achieve this, a large-scale, tightly controlled exercise clinical trial coupled with acute molecular response studies is needed.